Theory Assisted Design, Synthesis and Biological Activity of Bacteria-Targeting Nanostructures

Project Summary/Abstract
The goal of this project is to develop nanostructures that are selective for bacteria and to create a theoretical
framework (in silico model) that can be used to predict the activity of nanostructures and their behavior and
interactions with bacteria. Bacterial infections are a serious health problem that affects the human population.
Further, the emergence of resistant bacterial strains has made the problem even more serious. Two pathogens of
particular concern are Staphylococcus aureus and Acinetobacter baumannii. These pathogens are a main cause
of nosocomial skin and lung infections and are prevalent in immunocompromised patients and hospital settings.
To deal with these serious pathogens we propose to create nanostructures with intrinsic antibacterial activity that
can also target the bacteria by including siderophore molecules. In addition, we propose to develop theoretical
(computer) models that can be used to understand the biological action of the nanostructures and can be used to
design new nanostructures. To develop these systems, we have devised four specific aims. Specific Aim 1.
Computer-Guided Design of PA nanostructures. We will design several PA molecules and use theoretical
tools to select the PAs to be prepared. We will prepare nanostructures and test their antimicrobial activity and
cell toxicity. Specific Aim 2. Developing Bacteria Targeting Nanostructures. We will modify the best PA
molecules with siderophores. We will prepare nanostructures and test them against diverse bacteria. We will
also use the data to refine our MOLT system Specific Aim 3. Membrane Interactions and in Vivo Activity.
We will study the ability of nanostructures to disrupt membranes. We will also study the role of the siderophores.
Finally, we will evaluate their antibacterial activity using a Wax moth larvae in vivo model. Specific Aim 4.
Developing a Multi-Resolution Model model. We will combine the statistical mechanics and molecular
dynamic simulations to predict and understand the shape of the nanostructures, their activity. We will also study
the interactions of the PA nanostructures with membranes using both models. We will then combine the models
to get a better picture of the membrane disruption process. We will use the model to develop Quantitative
Structure-Activity Relationships that can be used to make better nanostructures.

Public health relevance
Project Narrative The goal of this project is to engineer supramolecular nanostructures that can target S. aureus and A. baumannii. In addition, we plan to develop a theoretical model that can guide the design of new nanoantibacterials.